Novel epigenetic mechanisms in neuronal development and cognitive function

Abstract: Intellectual disability (ID) affects 1-­3% of the population, resulting in cognitive and adaptive behavioral
deficits. Many genes are associated with ID, including multiple mutations in KDM5C, an X-­linked gene which we
discovered to be a histone demethylase a decade ago. In the past funding cycle, we found that KDM5C patient
mutations reduce both protein stability and catalytic activity. We showed that a mouse Kdm5c knock-­out (KO)
model recapitulated the cognitive and behavioral deficits seen in human patients. Kdm5c bound primarily at
promoters in terminally differentiated mouse neurons to modulate methylation at lysine 4 of histone 3 (H3K4),
and Kdm5c loss affected the expression of neuronal genes in the amygdala. Further studies of conditional mouse
Kdm5c KOs have suggested that Kdm5c potentially plays a neurodevelopmental role. To study the function of
KDM5C during neurodevelopment in a human model, we have generated patient-­derived iPS cell lines bearing
KDM5C mutations, and isogenic lines with the mutations corrected, both of which can undergo neuronal
differentiation in culture. These cell lines provide an unprecedented opportunity to explore the effects of KDM5C
in a well-­defined and experimentally accessible human developmental system.

The goals of this work are to obtain a comprehensive molecular and cellular understanding of how KDM5C
regulates human neurodevelopment. We will conduct high-­resolution time-­course analyses to determine exactly
which stages of neuronal differentiation, and which cell types, are compromised by KDM5C mutation. We will
investigate the functionality of KDM5C-­mutant neurons by interrogating the expression of synaptic markers and
electrophysiology. Because some aspects of brain development (e.g. formation of multiple cell types and their
organization) are not recapitulated in a 2D culture system, we will use 3D human brain organoids generated from
mutant and corrected iPS cells to investigate the roles of KDM5C in promoting brain growth, generating the
appropriate diversity of neural cell types, and facilitating neuronal network connectivity. Our findings will be
validated in vivo during embryogenesis of WT and Kdm5c KO mice, and the critical timing and location of Kdm5c
activity determined by expressing or deleting Kdm5c in specific stages/ cell types. To investigate the molecular
mechanisms of the neuronal differentiation defects in KDM5C mutant cells, we will determine transcriptional
profiles of mutant and corrected iPS cells during differentiation in 2D and 3D cultures. Because the critical
genomic targets of KDM5C (e.g. promoters, enhancers) during neurodevelopment are unknown, we will map
KDM5C binding sites genome-­wide during 2D neuronal differentiation, and determine how KDM5C mutations
alter the chromatin landscape. Finally, we will use biochemical approaches to identify KDM5C regulators, and
investigate their effects on KDM5C function and neurodevelopment. These studies will shed critical new light on
KDM5C function during neurodevelopment, and provide a basis for designing therapeutic strategies to treat ID.

Public health relevance
Project Narrative Intellectual disability (ID), a devastating disease, can be caused by mutations in a histone- modifying gene (KDM5C) that helps to control how DNA is organized within a cell, which ultimately determines which genes are turned on or off. Our goals are to investigate how KDM5C promotes normal brain development using human patient- derived cells and mouse models, and to determine how it influences DNA organization to turn appropriate genes on and off. These studies will provide a basis for developing strategies to treat ID.